Population-Based Analyses of Healthcare Utilization and Outcomes in Users of Medical Marijuana

PROJECT SUMMARY
Limited scientific consensus exists on the clinical, healthcare system, financial, or societal impact of
legalization of medical marijuana (MMJ) in states. The swift changes in state policies regarding MMJ use,
combined with the current national opioid epidemic, creates an impending need to better understand the
clinical, pharmacological, and behavioral impact of MMJ. The state of Arkansas approved MMJ use in 2016 by
individuals with select conditions, and dispensaries opened in May 2019. Unique data assets available through
the Arkansas Healthcare Transparency Initiative and the Arkansas Health Data Initiative (HDI) consist of
individually linked but de-identified mandatory all-payer claims, vital statistics, hospital and emergency
department (ED) discharge, and state police motor vehicular crash data, along with data on individuals who
qualify for MMJ use. This will be the first population-level analysis that measures clinical and adverse events in
a population of MMJ users and non-users through three specific aims:
Specific Aim 1: Describe demographic, geographic, socioeconomic, and clinical characteristics; healthcare
utilization, adverse events (new mental health diagnoses, substance abuse/overdose, suicide, accidental
injury, or MVA accidents); and opioid and benzodiazepine use among three groups: 1) individuals eligible
for MMJ in Arkansas who do not obtain an MMJ card (non-cardholders) , 2) individuals who are eligible
and obtain a MMJ card but do not purchase MMJ (cardholders), and 3) those who are eligible, obtain a
card, and purchase MMJ (consumers).
Specific Aim 2: Compare 12-month pre- and post-healthcare use and costs (inpatient and outpatient care, ED
visits, and prescription medications), and adverse events between consumers and non-cardholders. As a
sub-aim, we will evaluate changes in opioid and benzodiazepine utilization after commencing a course of
MMJ therapy.
Specific Aim 3: Examine the impact of COVID-19 on MMJ cardholder requests, MMJ purchases, healthcare
use, and adverse events.
This project brings together five data sources to examine the impact of MMJ on Arkansans. This includes
the Arkansas All Payer Claims Database (APCD), the MMJ registry, vital statistics files, and data documenting
emergency department visits and MVAs. These data are linkable at the person level which allows person-level
analyses or healthcare utilization and outcomes. This will be the first population-level analysis that measures
clinical and adverse events in a population of MMJ users and non-users.
Results of this research will help fill the gap in scientific knowledge by determining whether MMJ use has
benefits (e.g, decreased healthcare use and cost, substitution opioids and benzodiazepines) while producing
no additional harm (e.g., new mental health diagnosis, MVAs) and thus inform future MMJ policy.

Public health relevance
PROJECT NARRATIVE Since 2016 when the state of Arkansas approved the use of medical marijuana (MMJ) for 18 conditions verified by a physician, >500,000 Arkansans have been deemed eligible for MMJ use, >77,000 have obtained an MMJ card, and >10,000 pounds of MMJ have been purchased since the first dispensary opened in May 2019. The overarching goal of this project is to evaluate the impact of this state policy and its implementation on healthcare use, costs, and adverse outcomes by studying a population-based cohort of individuals, and to assess substitution effects of MMJ on high-dose opioid use. Results will inform clinicians and policymakers of the population-based benefits of MMJ.